Training Program in Environmental Health Sciences

This is a renewal application for continued support of the longstanding (41th year), Johns
Hopkins University NIEHS Training Program in Environmental Health Sciences (EHETG), which has supported 57 current and former predoctoral students and 19 current and former
postdoctoral trainees over the last 10 years. The former trainees are in research career
positions in academia, government, and private health-related industry, while 15 predoctoral
and 3 postdoctoral trainees are currently in training. Current and former trainees have published
over 168 peer-reviewed scientific papers during their training. To achieve the mission of the
NIEHS of discovering how the environmental affects people in order to promote healthier lives,
there is a critical need to prepare future scientists to address the complex current and future
pressing environmental health challenges. Thus, the goal of this T32 is to provide the research
foundation for predoctoral and postdoctoral scientists to become future leaders of
multidisciplinary research projects that seek to understand the role that environmental
exposures play in the etiology and exacerbation of human disease and apply this knowledge to
develop prevention and intervention strategies. The EHETG training program is uniquely
situated to make important contributions by being anchored within the dynamic, collaborative
atmosphere at the Johns Hopkins Bloomberg School of Public Health (BSPH) and has received
significant institutional support for the program, that has greatly enhanced the training mission.
Our multi-disciplinary mentoring team (27) derived from multiple departments across BSPH (3)
and the Johns Hopkins School of Medicine (2) has substantial funding that provides a wealth of
opportunities for original research by both pre- and postdoctoral trainees. Our predoctoral
trainees will participate in: 1) a rigorous, core curriculum in environmental health sciences that
provides the academic foundation for environmental health scientists (epidemiologic methods,
exposure sciences, toxicology, biostatistics and advanced data science skills); 2) specialized
innovative coursework in one of 3 focus areas (environmental exposures and environmental
epidemiology (ESSE); toxicology, physiology, molecular mechanisms (TPMM), and
environmental sustainability, resilience and health (ESRH) that support dissertation research;
and 3) dissertation research. All trainees receive instruction in the use of cutting-edge
technologies, advanced data sciences, Responsible Conduct of Research, grant writing,
research communications, and have access to career development activities. The research
being conducted by the mentor-trainee teams address one or more of the following topics: (a)
Defining the environmental exposures linked to human disease; (b) Mechanisms of disease
pathobiology; (c) Development and application of biomarkers of pathobiology; and (d)
Development of intervention and mitigation strategies to create healthy sustainable
communities. In this renewal application, we request critical support for 3-4 pre-doctoral
students/year and 4 post-doctoral trainees/year for the Training Program in Environmental
Health Sciences.
Modified

Public health relevance
Project Narrative This long-standing training program in Environmental Health Sciences at Johns Hopkins University provides state of the art training for the next generation of scientists in environmental sciences with the purpose of detection and evaluation of the health impacts of hazardous environmental agents on humans and the development of prevention/treatment strategies that will mitigate the impact of these exposures on human health.